Decreasing Disparity in Lung Disease: Pulmonary Rehabilitation for Rural Patients with COPD

PROJECT SUMMARY
Chronic obstructive pulmonary disease (COPD) is a leading cause of morbidity and mortality worldwide.
Globally, COPD prevalence is estimated to be 11.7%, and COPD is the fourth leading cause of death in the
United States (US). The age-adjusted prevalence of COPD is double in rural (8.2%) compared to urban areas
(4.7%). Rurality is associated with worse COPD outcomes, such as more severe dyspnea, poorer self-
rated health, lower health-related quality of life (HRQL), and increased risk of acute exacerbations. Significant
geographical disparities exist in treating and managing COPD in the United States. Less than 8% of rural
patients have access to pulmonary rehabilitation, a critical treatment for COPD patients that improves
all outcomes and decreases health care utilization. This project addresses an important SDOH
problem: access to proper care. It will provide pulmonary rehabilitation that promotes physical activity and
exercise, as well as customized education with personalized support through health coaching for patients with
COPD in rural areas. Our prior NIH-funded research in the delivery of Home-based rehabilitation, in addition to
the current literature, supports the scientific rationale and need for a clinical trial to test the proposed
hypothesis.
This application aims to test the uptake, effectiveness, and patient-caregiver-provider experience of home-
based pulmonary rehabilitation with health coaching for COPD patients in rural communities.
The proposed research that addresses access to care as the main social determinant of health will consider
patient/community priorities, needs, and preferences through a personalized approach through health
coaching. The program has been tested effective in two large NIH-funded randomized studies but not
specifically tested in rural settings. The comprehensive qualitative assessment of the intervention will inform
any necessary adaptation.
The proposed intervention will address two aspects of social injustice in COPD: inadequate COPD care and
lack of support (factors that make living with COPD more difficult than it should be, i.e., social isolation in rural
areas). If the project aims are achieved, an increased pulmonary rehabilitation uptake and improved physical
and emotional quality of life will advance the scientific knowledge, technical capability, and/or clinical practice
of rural patients living with COPD. Our results may inform the remote care for other chronic conditions in rural
patients (heart failure, hypertension, obesity, diabetes).

Public health relevance
PROJECT NARRATIVE Chronic obstructive pulmonary disease (COPD) is a leading cause of morbidity and mortality worldwide, and rurality is associated with worse COPD prevalence and outcomes. This application aims to test the uptake, effectiveness, and patient-caregiver-provider experience of a crucial treatment not provided in rural areas: pulmonary rehabilitation. The proposed intervention will provide home-based pulmonary rehabilitation to every patient recruited and will address access to care as SDOH and two aspects of social injustice in COPD: inadequate COPD care and lack of support for rural patients.